Vectorized scFv antibodies to treat tau pathology in Alzheimers disease enhancing epitope targeting and delivery strategies

PROJECT SUMMARY/ABSTRACT
Increasing evidence supports the existence of tau as an extracellular protein, and the concept of its trans-cellular
propagation as a mechanism for the initiation and progression of Alzheimer's disease (AD). In this context, using
antibodies to target tau pathology appears as an appropriate approach to clear neurofibrillary tangles in AD
models. In preclinical models, conventional tau immunotherapy has achieved only incomplete clearance of tau
pathology and presents limitations in terms of potential inflammatory adverse events, long-term sustainability,
compliance and costs. Also, effective blood brain barrier penetration and choice of the correct tau epitope are
still subject of an open debate. In clinical trials, several antibodies directed against tau’s N-terminus did not exert
any benefit in participants with prodromal/early onset AD or other tauopathies, raising the question as to whether
the antibodies in use are engaging the right epitope of tau at the right time. Some recent studies have
demonstrated, in in vitro and preclinical models, the advantage of targeting central-tau epitopes in preventing
tau seeding and propagation. In this supplement application, we will apply our extensive experience in the
generation and handling of anti-tau monoclonal antibodies and their recombinant variants in the context of
immunotherapy. Here we propose to generate new anti-tau antibodies, sequence, and turn them into scFv with
the intent to broaden the tau immunotherapy-pipeline.

Public health relevance
PROJECT NARRATIVE Several anti-tau antibodies tested in clinical trials did not exert any benefit in participants with early onset AD or other tauopathies, raising the question as to whether the antibodies in use are engaging the right epitope of tau at the right time. The therapeutic potential of antibodies to treat neurodegenerative diseases is also limited due to the difficulty of crossing the blood-brain barrier (BBB) and reaching target molecules in the brain. The objective of this study is to develop a new series of anti-tau monoclonal antibodies to enrich the anti-tau pipeline and to translate them into vectorized scFvs to be tested in vivo employing the same immunotherapeutic protocols described in the parent application.